Integration and Arrhythmia Suppression with hESC-Derived Cardiomyocyte Grafts

DESCRIPTION (provided by applicant): Because of their tremendous capacity for in vitro expansion and ability to differentiate into phenotypically unambiguous cardiomyocytes, pluripotent human embryonic stem cells (hESCs) are an attractive source for cell-based cardiac therapies. Our group has exciting new data indicating that hESC-derived cardiomyocytes (hESC-CMs) can couple with host myocardium following transplantation in guinea pig hearts, but their integration is imperfect in injured hearts. We have also found that hESC-CM transplantation significantly decreases the incidence of both spontaneous and induced arrhythmias. The present application builds on these observations and has two overall goals: first, to determine the mechanistic basis for this arrhythmia-suppressive effect and, second, to test novel approaches to further enhance the electromechanical integration of hESC-CMs in injured hearts. In Aim 1, we will test the hypothesis that the beneficial effects of hESC-CM transplantation on electrical stability correlates with their functional incorporation. In Aim 2, w will test the hypothesis that treatment with gap-junction modifiers will improve host-graft coupling following hESC-CM transplantation in a guinea pig infarct model. Finally, in Aim 3, we will use in vitro models to develop Wnt5a-mediated chemotaxis as a complementary strategy to improve the integration of hESC-CM grafts.

Public health relevance
PUBLIC HEALTH RELEVANCE: Arrhythmias are a major cause of death after a myocardial infarction ("heart attack"), but preliminary studies suggest that the transplantation of stem-cell-derived cardiomyocytes (heart muscle cells) can greatly reduce the incidence of post-infarct arrhythmias. The experiments proposed in this application will investigate the mechanistic basis for this anti-arrhythmic effect and explore new strategies to further enhance the electrical integration of stem-cell-derived cardiomyocytes in injured hearts.